Center for accelerated development of drug candidates targeting high threat bacterial infections

SUMMARY
In the face of a global crisis of antimicrobial resistance (AMR) in bacterial infections, the imperative for effective
new treatments is urgent. Our vision for the Center of Excellence in Translational Research (CETR) is to establish
a top-tier drug accelerator dedicated to advancing antibiotic development, focusing primarily on combating high-
threat multidrug-resistant bacteria. Drawing on expertise from leading drug developers within the academic
(CDI, Rutgers) and pharmaceutical/biopharmaceutical sectors (Merck, Prokaryotics), this CETR aims to
drive forward advanced antibacterial small molecule inhibitor programs, positioning them as preclinical
development candidates for multiple IND submissions. The Administrative Core plays a pivotal role in
optimizing research operations and resource allocation, closely aligning with Project Leaders and Core Directors.
This centralized structure fosters seamless communication, overseeing all operational aspects to ensure
efficiency and cohesion. Our comprehensive support system encompasses grant management, secure data
sharing, intellectual property protection, internal and external reporting, conflict and fiscal management,
collaboration communications, and data dissemination aiming to maximize project execution efficiency. Synergy
among projects is cultivated by leveraging diverse chemistries toward shared pathogens or molecular targets,
complemented by the Center’s collaborative ecosystem that fosters accelerated drug discovery. Guided by a
robust plan crafted by experienced drug development experts and a world-class Scientific Advisory Board
(SAB), we will navigate drug candidate development, employing pharma-style decision-making with clear 'go,
no-go' criteria to expedite and prioritize the most promising candidates. Building on past CETR successes and
existing partnerships, the program will support the development of novel chemical classes, conducting
comprehensive preclinical IND-enabling studies, ensuring regulatory compliance, promoting data sharing, and
fostering capacity building. Additionally, commercial partners and external regulatory support will aid in
navigating IND submission requirements. Through a robust administrative infrastructure and a seasoned
management team, our CETR is optimally positioned to achieve its drug development objectives resulting in
critical new therapies addressing the pressing issue of multidrug-resistant bacterial infections, thus safeguarding
public health globally.